Project 2: Improved Presymptomatic Diagnosis in Aicardi Goutieres Syndrome

Summary/Abstract for Project 2: Improved Presymptomatic Diagnosis in Aicardi Goutières Syndrome
Aicardi Goutières Syndrome (AGS) is an inborn error in RNA and DNA metabolism resulting in an early-onset
(neonatal or in first two years of life) leukodystrophy with extensive multisystemic disease and severe morbidity.
Off-label use of bariciticib, a janus kinase inhibitor, is now considered standard of care in this disorder. There is
a common prodromal period of systemic symptoms, although the diagnosis is typically made after neurologic
regression. This results in delayed treatment and irreversible neurologic injury. Thus, there is an urgent, unmet
need for newborn screening (NBS) to support early diagnosis and intervention to improve outcomes for children
affected by AGS. We propose to define novel analytic approaches to detect IFN related proteins and identify the
most sensitive and specific interferon signaling genes in retrospectively collected natal NBS cards from AGS
patients. Aim 1 will establish immunoassay approaches for IFN-related protein detection as a NBS biomarker in
AGS. Using AGS and control NBS card punches, we will perform iterative testing of 10 candidate antigens using
commercially available ELISA antibodies. The antigen with the best sensitivity and specificity will then be
developed into a first-tier newborn screening of AGS. Aim 2 will resolve elevation patterns of IFN-related genes
in AGS NBS as a second tier screen. We already have extensive published experience in ISG use in post-natal
AGS samples and the primary goal of this aim is to assess the appropriate cut-off points and genes of interest
in a NBS sample. This will be done by evaluating ISG scores and mRNA profiles of at least 48 IFN response
genes. Aim 3 will pilot the use of a two-tiered IFN protein/gene expression assay in a retrospective newborn
cohort. This will entail 50,000 existing deidentified newborn screening blood spots as well as blinded positive
controls undergoing the testing procedures as outlined in aims 1 and 2 as well as genetic testing. We anticipate
that these aims will define the diagnostic workflow for AGS in the context of newborn screening: IFN-related
protein measurement by immunoassay, then IFN-related RNA measurement via nanoString®, followed by genetic
confirmation.